Network-based study design, statistical, and modeling solutions for HIV among populations that use illicit substances: Informing interventions and policy in real-world settings using existing data

Project Summary/Abstract
Young black men who have sex with men (BMSM) experience a disproportionate burden of HIV
infection despite advances in HIV treatment and prevention, and their HIV risk often involves illicit
substance use. These individuals are frequently part of sexual networks with HIV transmission risk. HIV
interventions have the potential for substantial impact beyond the treated individual. This is known as
spillover (i.e., interference), and occurs when one participant's exposure affects another's health
outcome. Although spillover has been evaluated for therapies like vaccines, there is preliminary
evidence that HIV interventions result in meaningful spillover, such as treatment as prevention and pre-
exposure prophylaxis (PrEP). However, there have been limited evaluations of spillover in this
marginalized population. Important methodological work remains in the context of studies to evaluate
the spillover of HIV interventions among populations that use illicit substances. The objective of this
application is to evaluate the spillover of HIV interventions among marginalized populations
using both secondary data analyses of existing data and simulation approaches. This project will
provide new insights about spillover in the following network studies in Chicago, Illinois: uConnect,
PrEP Chicago, and Neighborhood and Networks Cohort Study. The development of sample size and
power formulas to evaluate spillover in sociometric network-based studies will facilitate post hoc
evaluations of power in the motivating studies. This will also allow investigators to conduct adequately
powered future studies of spillover to determine the most effective HIV interventions among young
BMSM. Network dependence and missing data in network-based studies are common and largely
unaddressed in the assessment of spillover. We will develop causal methods addressing both these
threats to valid inference. We will conduct a pre-deployment evaluation of spillover for HIV
interventions, including a PrEP peer change intervention and PrEP delivery focused on substance-
using agents in a calibrated agent-based network model of young BMSM in Chicago, Illinois. We have
assembled a transdisciplinary, expert team of leading methodologists, modelers, substance use
clinicians, and HIV prevention scientists, who also hold key leadership roles in the three motivating
network studies and agent-based network model. Resources at the University of Rhode Island will
provide a centrally-located environment to facilitate research, including collaborative opportunities with
leading HIV and substance use researchers. This project will advance modeling and statistical
methodology for HIV prevention among marginalized populations to assess spillover and contribute
important substantive studies of spillover in both secondary data analysis and agent-based modeling,
providing novel insights to advance HIV prevention and treatment among young BMSM.

Public health relevance
Project Narrative This project will provide novel insights for HIV interventions among marginalized populations that use illicit substances by studying spillover in HIV risk networks with potential for applications to other infectious diseases and intervention research methodology. Despite advances in HIV treatment and prevention, young black men who have sex with men (BMSM) experience a disproportionate burden of HIV infection and critical work remains to evaluate the potential for benefit beyond the treated individual (spillover) in these interconnected HIV risk networks among BMSM. We propose to evaluate spillover of HIV interventions in marginalized populations using both secondary data analyses of existing data and simulation approaches requiring the development of novel study design, inferential, and modeling methods.